PD-1/PD-L1 signaling at the interface between immune and stem cell crosstalk

Project Summary
This project proposal is designed to elucidate the nature of immune-stem cell interactions that are
inadvertently targeted by immunotherapies. Specifically, we focus on signaling between the immune
checkpoint proteins programmed cell death 1 (PD-1) and programmed cell death ligand (PD-L1) as one
mechanism by which immune cells and stem cells coordinate tissue immunity with tissue regeneration. We use
melanocyte stem cells (McSCs) and hair repigmentation as the model. Our rationale for this proposal stems
from our discoveries that 1) PD-L1 is expressed at the right time (during hair dormancy) and the right place (by
quiescent McSCs in the hair follicle) to regulate both McSC immune privilege and quiescence; 2) blocking PD-
L1 in this cell lineage increases cell cycling in vitro, and 3) blocking PD-L1 provides resistance to stress-
associated hair graying in vivo. Further rational derives from the literature— PD-1/PD-L1 immune checkpoint
inhibitor therapy for cancer causes two opposite pigmentation/immune-related adverse events (irAEs). On one
hand we see vitiligo-like hypopigmentation in melanoma patients but on the other hand we see reversal of gray
hair in non-melanoma patients. The objectives of our study are to decipher how PD-L1 enables crosstalk
between McSCs and neighboring immune cells to regulate McSC immune privilege, maintain McSC
quiescence, and balance the immunogenic and tolerogenic processes within the skin to enable pigment
regeneration.
To complete these objectives, we have assembled a team of experts in stem cells, pigmentation and hair
biology, mouse transgenics, inflammatory disease models and immunology. With this combined expertise, we
will investigate the regenerative capacity of McSCs in combination with adoptive transfer of Jedi T cells, anti-
PD-1 and anti-PD-L1 antibodies that mimic human immunotherapies, and in the context of a novel mouse
model of post-inflammatory skin hypopigmentation. We will also employ McSC lineage tracing and our novel in
vitro quiescence assay to further interrogate PD-L1 function in cell cycling. The results of these studies are the
foundation to addressing a critical question in the field of immunotherapy. How do we do we tip the balance
towards immunotherapy’s undeniable benefits and away from its irAEs? The diversity of irAEs, the organs they
affect, and their onset and severity suggest immunotherapy has numerous targets that do not all represent the
same basic pathology. Thus, revealing the underlying biology behind individual immune-related toxicities is key
to harnessing the full potential of immunotherapy treatment. This study will also provide insight into the
immune-stem cell dialog enabled by PD-1/PD-L1 signaling. More broadly, this study contributes to the growing
paradigm that immune cells and stem cells mutually regulate one another’s behavior to orchestrate
regenerative tissue homeostasis and repair in the context of tissue immunity.

Public health relevance
Project Narrative Immune checkpoint inhibitors have revolutionized cancer therapy, but these treatments are often accompanied by immune-related adverse events that tempers their benefits. In particular, treatment with PD- 1/PD-L1 immunotherapy includes off-target changes in skin and hair pigmentation and these side effects point to roles for the PD-1/PD-L1 proteins in coordinating the crosstalk between immune cells and stem cells that is necessary for normal tissue regeneration. Using these side effects as our guide, we will elucidate the underlying biology behind the pigmentation associated changes caused by PD-1/PD-L1 immunotherapy, which is a critical first step to refining this immunotherapy treatment for improved clinical outcomes with little to no negative effects.